Project 3: Prevention and Treatment of Hearing and Vision Impairments for Reducing AD/ADRD risk

PROJECT SUMMARY/ABSTRACT
Sensory impairments, including hearing and vision loss, affect up to 40% of older adults and have been linked
to higher risk of Alzheimer’s disease and Alzheimer’s disease related dementias (AD/ADRD). Identification and
treatment (or corrections) of hearing and vision impairment could be a high-impact strategy for AD/ADRD
prevention, yet uncertainty remains about whether these strategies are likely to deliver true benefits. Large and
diverse longitudinal studies offer advantages over intervention trials to understanding the long-term impacts of
sensory impairment and their treatments on population-level AD/ADRD burden. However, estimating causal
effects of sensory impairment and treatments using observational data requires sophisticated methods to
address potential bias from confounding, reverse causation, selection bias, and measurement error.
Furthermore, the effect of sensory impairment on AD/ADRD may be modified by other risk factors including
sex/gender, race/ethnicity, socioeconomic status, genetic risk, and cardiovascular comorbidities. Understanding
heterogeneity by social strata is essential to anticipate the potential impacts of interventions of sensory
impairment on reducing AD/ADRD inequities. Few prior studies have implemented such methods or
comprehensively evaluated heterogeneity by population subgroups. Our overarching goal is to rigorously
evaluate the influence of sensory impairment and treatment of sensory impairments on AD/ADRD risk using
modern causal inference methods and a data triangulation framework, which is a process of integrating evidence
from multiple study designs and settings. Our secondary objective is to leverage multiple data sources to
evaluate heterogeneity of effects in diverse populations and whether sensory impairments contribute to social
inequities in AD/ADRD incidence. We will leverage 3 diverse longitudinal cohort studies complemented by other
large-scale samples with integrated health care and genetic information to conduct our specific aims. Following
our data triangulation framework, we will estimate whether hearing impairments and vision impairments increase
risk of AD/ADRD (Aim 1) and whether treatment of impairments in hearing (hearing aid use) or vision (cataract
surgery) reduces risk of AD/ADRD (Aim 2). Under Aim 3, we will examine heterogeneity (effect modification by
other AD/ADRD risk factors (social factors, genetic risk, cardiovascular risk factors) in the estimated effects
obtained in Aim 1 and 2. Finally, we will quantify reductions in AD/ADRD social inequities that could be achieved
through prevention or treatment of hearing or vision impairments. The integration of this project within the TIME-
AD program, our team’s expertise in cognitive aging, sensory impairment epidemiology, and the use of the
proposed methods and data sources will uniquely enable us to accomplish our aims. This study’s findings will
provide critical insight into whether prevention or treatment of hearing and vision impairment should be high
priorities in efforts to reduce AD/ADRD incidence and inequities.